Scalable and transplantable pancreatic islet organoids with engineered oxygenation

PROJECT SUMMARY
Pancreatic islet transplantation is a therapeutic option for type 1 diabetes (T1D), providing glycemic control and
eliminating the need for insulin injections. It offers the advantage of a less invasive, catheter-assisted procedure
compared to another surgical intervention, whole pancreas transplantation, which carries high surgical
complication risks. However, the long-term success of islet transplantation is limited, with the insulin
independence rate dropping to ~10% of patients after five years. This is in contrast to whole pancreas
transplantation, which achieves higher insulin independence rates of >70% at five years post-transplant. The
key difference lies in the loss of the islet microenvironment during isolation for islet transplantation; disrupting
vasculature and extracellular matrix support leads to significant graft attrition. This underscores the need for
creating an islet-supportive microenvironment. Fabricating an islet organoid in vitro-with interactions between
islets and supporting cells prior to transplantation-is a promising solution. However, fabricating a clinically
scalable organoid has been challenging due to the insufficient oxygen supply to the organoid core. Our longterm
goal is to develop clinical-scale transplantable islet organoids that incorporate an islet-supportive
microenvironment to improve islet engraftment efficiency in T1 D patients. In this application, we propose a
practical approach to deliver oxygen to the diffusion-limited organoid core. We engineered oxygen-transporting
microcapillary mesh made from clinically proven parylene material. Oxygen is delivered through the ultra-thin
25-μm microcapillary mesh via passive diffusion from the surrounding environment. This achieves a uniform and
self-sustaining oxygenation throughout the organoid. We hypothesize that establishing an islet-supportive
microenvironment within an islet organoid, prior to transplantation, will improve post-transplant engraftment. We
will test this through the following Specific Aims: Aim 1: Fabricate scalable human islet organoids using oxygen
transport from culture media in a dynamic culture system. Aim 2: Fabricate scalable human islet organoids using
oxygen transport from ambient air in a static culture system. We will fabricate human islet organoids of 5 mm in
thickness that far exceed the general oxygen diffusion limit of ~50-100 μm. The organoids will be integrated with
multiple layers of our oxygen-transporting mesh to deliver continuous oxygen to the core. We will use human
cadaveric and stem cell-derived islets as potential insulin-producing cell sources and transplant these organoids
under the skin in diabetic immunodeficient animals to assess the therapeutic benefits compared to conventional
islet transplantation. These aims share the same concept-delivering oxygen into the organoid core through the
oxygen-transporting mesh-but employ distinct oxygen sources with mesh modifications. Successful completion
will demonstrate a scalable solution in large organoid fabrication. This research aligns with the mission of the
NIDDK by integrating cross-cutting science in biology, physiology, and engineering using a unique device to
address a critical gap in T1D treatment, with implications for multiple organoid-based therapies.

Public health relevance
PROJECT NARRATIVE: Transplanting insulin-producing pancreatic islet cells offers a promising solution for type 1 diabetes by achieving natural glycemic control without the need for synthetic insulin injections. Creating transplantable islet organoids with an islet-supportive niche is ideal for improving engraftment, but clinical-scale fabrication has been challenging due to poor oxygen penetration, which leads to organoid death at the core. We address this limitation through a novel, clinically scalable technology using an ultra-thin microcapillary mesh to efficiently deliver oxygen throughout the organoid, significantly enhancing the success rate of islet transplantation for the 1.6 million Americans affected by type 1 diabetes.